Creation of the Next Generation RNAi Therapeutics and an in vivo model for their study

Abstract
RNA interference (RNAi) – a natural biological mechanism by which eukaryotic cells control gene expression –
can be used to target and silence with high specificity virtually any expressed gene, making it a potentially
powerful therapeutic approach. Importantly, RNAi mechanisms utilize DNA/RNA sequences to specify its target,
enabling fine-tuned silencing of a single gene belonging to a family of structurally similar proteins that typically
share small molecule binding pockets. For these reasons, RNAi-based therapeutics have the potential to provide
effective on-target benefits while avoiding off-target toxicities that are commonly seen with promiscuous protease
and kinase small molecule inhibitors. Despite their therapeutic potential, the most challenging aspect of RNAi-
based drug development involves achieving effective delivery to the cells or tissues of interest, while avoiding
systemic off-target effects. Indeed, only a handful of RNAi-based drugs have received FDA approval to treat liver
diseases since this is the most readily accessible tissue for this class of drugs. More recently, alternative delivery
mechanisms, such as ligand-coupled oligonucleotides, lipid nanoparticles, viral vectors, and extracellular
vesicles (EVs) show great promise with the potential to penetrate tissues and have cellular uptake where they
can engage the endogenous RNAi machinery to induce gene silencing. However, a systematic method for
evaluating these delivery modalities in vivo has yet to be implemented. To overcome this hurdle, we generated
a murine model – the Optimus model, that contains a dual fluorescence reporter cassette where one reporter
harbors unique RNAi responsive elements. Using this Optimus model, we aim to generate an effective pipeline
to readily test an array of new RNAi-based therapeutic biologics generated by coupling our optimized siRNAs or
artificial miRNA scaffolds to established delivery vehicles, beginning with three unique modalities: 1) peptide-
based platform developed by SRI International for specific delivery to lung adenocarcinoma cells; 2) aptamer-
based modality developed by Aptamer group for the silencing in activated hepatic stellate cells under liver fibrotic
conditions; and 3) recombinant adeno-associated viruses (rAAV) we previously generated carrying ubiquitous
and tissue-specific RNAi expression cassettes. Importantly, these delivery platforms have already demonstrated
successful delivery of oligonucleotide payloads, both in vitro and preliminary in vivo. Our collaboration enables
us to further test these new therapeutic biologics in live animals and assess their biodistribution, the features
that promote cellular uptake and enable trafficking of RNAi payload for functional engagement, and the systemic
off-target effects at very early stages of pre-clinical development. This research will define a new paradigm to
accelerate the creation of novel RNAi-based (and potentially oligonucleotide-based) drugs and readily evaluate
their therapeutic potential in live animals.

Public health relevance
Narrative RNA interference (RNAi) – a natural biological mechanism by which eukaryotic cells control gene expression – can be used to target and silence with high specificity virtually any expressed gene, making it a potentially powerful therapeutic approach if the appropriate intracellular delivery vehicle can be deployed to reach tissues of interest. Here, we aim to establish an in vivo pipeline for scalable evaluation of novel RNAi therapeutics using established delivery platforms conjugated to our RNAi payloads. We will perform in vitro and in vivo assessment of select RNAi nucleic acid based therapeutics (NBTs) to evaluate biodistribution, systemic effects, and the inhibitory potential of a target gene using our dual fluorescence reporter model – the Optimus model – and their potential for future clinical use to treat human diseases.